The Impact of High Fat Diet on Brainstem Vagal Regulation

ABSTRACT:
Current understanding of cardiac parasympathetic (or vagal) activity unequivocally demonstrates that the vagal
activity to the heart and homeostatic reflex changes in cardiac vagal activity are mediated by cardiac vagal motor
neurons (CVNs) in the brainstem. Therefore, CVNs play an essential role in normal cardiovascular function.
Despite our understanding of CVN neurophysiology in health, the potential for CVN dysfunction in diseases is
still unclear. This is particularly true of our understanding of the complex interplay between cognition and
cardiovascular function. A distinctive hallmark of cardiovascular disease risk is low cardiac vagal signaling, and
the extend of this imbalance correlates strongly with increasing risk of developing Alzheimer’s Disease (AD), and
its related dementias. Preliminary data from our laboratory demonstrate that vagal activity to cardiac tissue is
reduced and that the vagal motor neurons responsible for this regulation are loss at late stages of disease. Our
overall hypothesis guiding this proposal is that CVN hypoactivity drives poor cardiovascular vagal tonus and
reflex responses. This hypoactivity will eventually lead to robust cell loss and further disease progression.
However, critical questions remain, including how quickly does the increased inhibition of CVNs occur and what
role does neuronal excitability play. Therefore, this proposal will 1) quantitively determine the timing of cardiac
vagal signaling in the 5XFAD mouse model of AD, and 2) establish the role of CVNs in the effects of early cardiac
vagal signaling in these mice. The anticipated results of these experiments will provide fundamental details in
our understanding of cardiac vagal regulation and mechanisms responsible for vagal regulation of heart rate.
Identifying the early mechanistic consequences of vagal activity could lead to the discovery of biomarkers, and
early testing of new therapeutics targeting disease mechanisms, rather than symptoms.

Public health relevance
PROJECT NARRATIVE: The role of cardiac vagal motor neurons in the regulation of cardiovascular function has long been established, but the contribution of this system to cardiovascular dysregulation related to the development of Alzheimer’s Disease (AD), and its related dementias is an understudied topic. These experiments will address the hypothesis that that loss of CVNs signaling to cardiac tissue through loss of brainstem CVN motor neuron activity occurs during early disease progression, promoting poor cardiovascular homeostatic regulation and global changes in central nervous system function, including prominent hallmarks of AD. This proposal develops a novel neuromechanistic model by which a microcircuit within the brainstem underpins vagal hypoactivity responsible for generation of vascular dysfunction leading to AD.